Control of dentate neurogenesis: Shh, mossy cells, activity and seizures

The dentate gyrus (DG) is one of two brain regions acknowledged to sustain neural stem cells (NSCs)
continuously producing neurons (termed “neurogenesis”) beyond development. Newborn neurons produced in
the DG are involved in hippocampal-dependent learning and memory. Thus, factors regulating establishment
of the NSC pool during development and their life-long maintenance are crucial for hippocampal function.
The fate of NSCs is governed by local microenvironmental factors, including neural circuit activity.
Hyperexcitation in the hippocampus caused by epileptic seizures aberrantly increases neurogenesis in the
adult DG, leading to consumption of many NSCs and results in exhaustion of the NSC pool. Despite
accumulating evidence that neuronal activity regulates NSCs dynamics, still little is known about the
responsible niche cells and signaling molecules connecting neural activity and NSC dynamics. Similar to the
adult DG, NSCs in the developing DG may also be influenced by activity, but whether NSCs are regulated by
early neural activity during circuit establishment in the developing DG has not been directly addressed.
In the previous funding cycle for this grant, we found that Shh is a key niche signal for the initial production of
specialized NSCs populating the DG and for their postnatal expansion to establish the size of the NSC pool for
later adult neurogenesis. In more recent preliminary data we have found that Shh signaling is upregulated after
seizures in the adult DG and that seizure-induced aberrant neurogenesis is attenuated in Shh deficient mice.
We previously showed that Shh is produced from excitatory neurons in the dentate hilus (mossy cells) but have
now extended this to show that mossy cell activity enhances neurogenesis. On this basis we have formulated
the hypothesis (for Aim 1) that Shh derived from mossy cells is crucial for neuronal activity induced DG
neurogenesis. We have also investigated the neuronal circuit in the developing DG and found that the entorhinal
cortex projection to the developing DG is established by the first postnatal week coinciding with the appearance
of quiescent NSCs in the DG. We have also found that NSCs receive direct inputs from local neurons in the
developing DG in this same period. Based on these preliminary results we formulated a second hypothesis (for
Aim 2) that development of cortex-dentate-NSCs circuits and their activity control the proliferation state and
transition to quiescence of NSCs in the developing DG.

Public health relevance
The production of new neurons throughout life in the dentate gyrus is critical for function of the hippocampus, and after seizures there is increased production of new neurons but the formation of abnormal circuitry. We have identified a role of mossy cells in the hilus in the production of a secreted factor that regulates dentate neurogenesis in an activity dependent manner. In addition, we examine the formation of developmental circuits in the dentate that regulate the development of the dentate stem cells.